Tuning multivalency for optimized ligand presentation

Project Summary/Abstract
This is an application for a Research Supplement to Promote Diversity in Health-Related Research to
complement our parent grant, “Tuning Multivalency for Optimized Ligand Presentation” (R35 GM138296). The
supplement funds will support Cesar Ramirez, who in Fall 2022 is starting his second year as a Ph.D. student in
my lab within the Department of Biomedical Engineering at Rutgers University. As a first-generation Hispanic
permanent resident from El Salvador, Cesar has shown incredible drive and passion to excel in academia and
science. Within the scope of this parent grant, Cesar will be developing quantitative structure-activity relationship
(QSAR) models that will allow us to accurately shape synthetic multivalent ligands with optimized biophysical
dynamics for programmable cell signaling. To achieve this ambitious goal, we have created a research and
career development plan that will maximize Cesar’s potential that is specifically tailored to his project and
personal needs. This plan will build on Cesar’s previous research experience and help him to develop
computational models for these complex biophysical interactions. Meanwhile, Cesar will continue with his
coursework and PhD candidacy requirements, while also applying for fellowship and internship opportunities. By
the end of this two-year and beyond training plan, Cesar will be ideally positioned for prestigious jobs in industry
or academia. The application of data-science towards the development of biomedical technologies is growing
exponentially, and Cesar’s unique experience/training will be highly valuable in this competitive job market. There
is no doubt that this will maximize Cesar’s potential to help transform the biomedical sciences.

Public health relevance
Project Narrative This is a diversity supplement request for PA-21-071, under award 5R35GM138296-02 (PI: Gormley, Adam).